Providence/Boston Center for AIDS Research (CFAR)

Long-acting injectable (LAI) antiretroviral treatment (ART) is a new alternative to help overcome the challenges
of adhering to daily oral ART. Nonadherence to ART can lead to viral rebound, HIV resistance, opportunistic
infections, and propagation of HIV transmission, yet LAI ART brings the hope of improved adherence, viral
suppression, and improved long-term control of HIV among persons who have struggled with adherence to oral
ART. Unfortunately, access to LAI ART for persons with HIV (PWH) has been complicated by administrative,
clinical, and logistical barriers. Despite the challenges, the Immunology Center of The Miriam Hospital/Brown
University in Providence, RI, has established a successful pharmacist-led LAI ART program and developed
pathways for medication approval, acquisition, storage, and patient assessment, education, counseling, and
monitoring. Given the success of this program, there is an opportunity to collaborate with HIV clinics in Ending
the HIV Epidemic (EHE)-designated jurisdictions to establish and optimize pharmacist-led LAI ART programs to
increase access to HIV treatment options and improve treatment outcomes. Investigators from The Miriam
Hospital/Brown University will collaborate with partners in Arkansas (an EHE-designated state) including the
University of Arkansas Medical Sciences, and the ARcare Positive Connections program, a Ryan White-funded
multi-site HIV clinic network in Arkansas, which has struggled with the roll-out of LAI ART. Using the Exploration,
Preparation, Implementation, Sustainment (EPIS) implementation science framework, Evidence Based Quality
Improvement (EBQI), and the principles of community engagement, we propose to examine lessons learned
from the Immunology Center LAI ART program, assess barriers to LAI ART rollout in the ARcare network, and
to develop and implement a sustainable pharmacist-led LAI ART program with assessment of patient outcomes
within the ARcare network. Our specific aims include: 1) Using the EPIS framework and EQBI, we will leverage
the experience of the Immunology Center LAI ART program (Explore) to develop, pilot test, and optimize an LAI
ART program that utilizes a Collaborative Practice Agreement between pharmacists and providers in two ARcare
clinics (Preparation, Implementation); and 2) We will expand the LAI ART protocol developed in Aim 1 across
three additional ARcare sites with re-examination of implementation barriers and facilitators and assessment of
patient outcomes and program sustainment (Preparation, Implementation, Sustainment). This study fulfills the
high priority HIV/AIDS research objectives of the National Institutes of Health including evaluating the use of the
next generation of HIV therapies that are longer acting and easier to take and adhere to than current regimens
and will provide critical data related to improving access to novel LAI HIV treatments; evidence that will contribute
to the EHE initiative in the U.S. Furthermore, data from this study will inform future implementation science
studies of LAI ART designed to increase access to LAI ART for vulnerable and marginalized PWH including
those with poor ART adherence, ART-naïve PWH, and active substance users.

Public health relevance
Long-acting injectable (LAI) HIV treatment is a new alternative to help overcome the challenges of adhering to daily oral medications, but access to LAI HIV treatment has been hampered by administrative, clinical, and logistical barriers. In this study, researchers from The Miriam Hospital/Brown University will collaborate with partners in Arkansas including the University of Arkansas Medical Sciences, and the ARcare Positive Connections program, a multi-site HIV clinic network which has struggled with the roll-out of LAI ART. Our goal is to to develop and implement a sustainable pharmacist-led LAI HIV treatment program within the ARcare network to improve HIV treatment outcomes in a state highly impacted by HIV.